Room Temperature Protein Conformational Dynamics at Microsecond Timescales

Project Summary: The structure, dynamics and function of a biomolecule play a key role in determining
disease mechanisms, knowledge of which is essential for early diagnosis, drug development and effective
treatment. Many biological studies focus on structure determination of biomolecules but the study of dynamics
is vital to understand disease mechanisms, including their function and interaction with their environment.
Compared to other biophysical methods, multi-frequency 2D Electron Spin Resonance (ESR) spectroscopy are
powerful methods for studying structural dynamics of proteins at physiological temperatures for a wide range of
time scales (sub-𝑛𝑠 to tens of 𝜇𝑠) and can provide a detailed description of motion that includes both dynamics
as well as local structural ordering. Despite major advances, multi-frequency 2D-ESR lack sufficient sensitivity
and resolution needed to study biological systems at 𝜇𝑠 timescales, because the signals are heavily dominated by
noise with Signal-to-Noise Ratios (SNRs) of unity and so are hardly visible. To address this problem, the
proposed research will develop computational methods based on wavelet transforms to remove noise for
accurate signal recovery. The proposed research is aimed at developing multidimensional wavelet denoising for
multi-frequency 2D-ESR signals at SNR ~ 1, extending the 1D wavelet denoising approach. Wavelet transforms
provide a powerful approach to remove noise as they focus on separating noise from the signal, an active subject
in the field of signal processing. The methods will include multi-dimensional representation of signals,
development of new wavelets, enhancement in signal resolution in the wavelet domain, and development of noise
thresholds based on well-defined statistical theorems, all of which will contribute to separate noise from signals.
A new criterion will also be developed and adopted to quantify noise and uncertainty. The new denoising
methods will be applied to reveal conformational dynamics of a well-characterized T4 Lysozyme protein and to
understand lipid-transmembrane interactions ranging from 𝑛𝑠 to tens of 𝜇𝑠 time scales at physiological
temperatures and concentrations for understanding signaling pathways related to diseases. This will lead to a
detailed understanding of protein dynamics at the time scale of exchange between conformational substates and
will create a platform for which motions of biological complexes can be studied, which currently remains elusive
and are of key functional importance. Measurement of exchange rates under physiological conditions is a new
experimental frontier and lifetimes in the range of 𝜇𝑠 are anticipated. It will also lay the foundation for using
data processing methods to remove noise from experimental signals and permit their application during data
acquisition for real-time processing. Data processing methods are inexpensive, easy-to-implement, and easily
scalable to existing instruments.

Public health relevance
Project Narrative: To combat diseases, it is essential to study the function of biomolecules to understand the underlying disease mechanisms. Multi-frequency Electron Spin Resonance (ESR) spectroscopy, which is a powerful method to study functional dynamics of proteins, lacks sufficient sensitivity and resolution to carry out studies at physiological concentrations and longer time scales. The proposed research will develop computational methods to improve signal resolution in ESR spectroscopy, enabling better understanding of disease mechanisms for more effective therapies, thus benefiting the public health.